COMBINED SULFONYLUREA/INSULIN THERAPY IN PATIENTS WITH NIDDM

The purpose of this study is to determine the efficacy of bedtime NPH insulin alone or in combination with oral sulfonylurea treatment of hyperglycemia in patients with non-insulin dependent diabetes. This will include insulin clamp studies to determine insulin sensitivity prior to and after optimization of glycemic control.